User customization and user optimization of cochlear implant devices

DESCRIPTION (provided by applicant): The current fitting approach adopted for cochlear implant (CI) users falls along the lines of one-size-fits-all, in that it is assumed that the initial fitting in the clinic should work equally well in all listening environments. Speech coding algorithms and associated parameters (e.g., compression function) are fixed and are not optimized in any way by either the patient or clinician for different listening situations (e.g., quiet, music, noise). The present study addresses this major limitation with the use of a portable research speech processor that allows users to: (a) change MAP parameters based on two different outcome measures (subjective quality ratings and consonant intelligibility) (b) customize the MAP to different listening situations for maximum benefit, and (c) collect feedback and allow the recording of real acoustic signals for further analysis. In this study, unilateral, bilateral and bimodal users will participate in double-blind field trials to assess the true benefit of a speech processor that can be easily customized by the users to fit their needs based on subjective quality ratings or speech intelligibility measures. The overarching hypothesis of this project is that maximum benefit, both in terms of subjective quality and intelligibility, can be obtained when the cochlear implant devices are customized (by the users) to the various listening situations. The outcomes of the field studies will tell us about the difficulties experienced by CI users in real-world situations as well as the value and additional benefit of customizing speech coding algorithms to different environments, all based on feedback from CI users. Such feedback and user interaction can not be gathered using existing commercial processors, yet it is critically needed to move the field forward.

Public health relevance
PUBLIC HEALTH RELEVANCE: The outcomes of this work can greatly benefit the overall quality of life for a large number of cochlear implant users. Cochlear implant users who are able to communicate effectively in noisy environments have greater opportunity for integration into mainstream education, increase their productivity at home or work and contribute more in the nation's economic growth and competitiveness. Project Narrative The outcomes of this work can greatly benefit the overall quality of life for a large number of cochlear implant users. Cochlear implant users who are able to communicate effectively in noisy environments have greater opportunity for integration into mainstream education, increase their productivity at home or work and contribute more in the nation's economic growth and competitiveness. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Despite the many advances made in the design of novel speech coding algorithms and electrode arrays, the cochlear implant (CI) fitting process lags behind. The current fitting approach falls along the lines of "one-size- fits-all", in that it is assumed that the initial fitting in the clinic should work equally well in all listening environments. Other than the psychophysical mapping (e.g., T and M levels), the speech coding algorithms and associated parameters (e.g., compression function, filter spacing) are fixed and are not optimized in any way by either the patient or clinician for different listening situations (e.g., quiet, music, noise). In situations where patients wear a hearing aid (HA) in one ear and an implant in the other (bimodal users) or wear two implants (bilateral users), the fitting is done separately for each implant, rather than jointly. The above issues limit severely our ability to tap into the full potential of existing CI devices, which are currently not customized to individual users for different listening environments. The present study addresses the above limitations with the use of a portable research speech processor that allows users to: (a) change MAP parameters based on two outcome measures, (b) customize the MAP to different listening situations for maximum benefit, and (c) collect feedback and recordings of real acoustic signals for further analysis. Unilateral, bilateral and bimodal users will participate in double-blind field trials to assess the true benefit of a speech processor that can be easily customized by the users to fit their needs and subjective quality judgments. The overarching hypothesis of this application is that maximum benefit, both in terms of subjective quality and/or intelligibility, can be obtained when the CI devices are customized (by the users) to the various listening situations encountered by CI users. Aim 1: User-customization and user-optimization of unilateral cochlear implants Unilateral users will participate in two trials. In the data-acquisition trial, subjects will be given the research processor and asked to record acoustic signals in six listening environments they find most challenging. After bringing the recordings to the lab, an environment-optimized suppression algorithm will be developed and given to the patients to evaluate in a double-blind field trial. Patients will also be allowed to adjust speech coding parameters based on two outcome measures, including quality judgments along three dimensions (clarity, brightness, overall impression). In another study, subjects will be given a self-adjustable research processor that automatically identifies the environmental noise and activates the appropriate coding algorithm. These studies will (1) provide valuable information about the benefit that can be obtained when CI users are allowed to adjust/customize their speech processors to different listening situations, and (2) determine whether the subjective quality measures provide better distinction between various experimental MAPs in situations where ceiling/plateau effects are observed with the intelligibility measure. Aim 2: User-customization and user-optimization of bilateral cochlear implants Current bilateral devices operate independently and are often fitted separately and differently. As such, no (binaural) intelligent processing can be implemented to better exploit the location of the interfering signals in real situations or to exploit the access to multiple microphones for better noise suppression. The experiments proposed in this aim will address these limitations and will assess the performance of coordinated bilateral stimulation, in which the microphone signals collected from the two implants are re-directed so as to provide better noise reference to beamforming-like algorithms. Bilateral cochlear implant (BiCI) users will participate in double-blind field trials to assess the real benefit of coordinated, rather than independent, bilateral stimulation. It is hypothesized that coordinated bilateral stimulation will allow BiCI users to better localize sounds and subsequently obtain a squelch benefit. Aim 3: User-customization and user-optimization of bimodal devices Bimodal devices (hearing aid in one ear and cochlear implant in opposite ear) suffer from the same limitations as bilateral devices in as far as not being optimally fit. For instance, no gain is applied to either the acoustic or electric signals to compensate for the differences in non-linear growth of loudness in acoustic and electric hearing. In the proposed experiments, it is hypothesized that for maximum bimodal benefit it is necessary to apply different gains to the acoustic and electric signals. Different methods for selecting these gains are investigated in double-blind field trials, including a method that automatically adjusts the gains based on acoustic and electric loudness models. The outcomes of the above field studies will tell us about the difficulties experienced by CI users in real-world situations as well as the value and additional benefit of customizing speech coding algorithms to different environments, all based on feedback from CI users. Such feedback and user interaction can not be gathered using existing commercial processors, yet it is critically needed to move the field forward.